Functional diversity of somatostatin interneurons in visual cortical circuits

Project Summary:
GABAergic interneurons are central to the normal development and function of neocortical circuits. In
particular, cells that express the peptide somatostatin (SST-INs) are thought to play critical roles in both
spontaneous and sensory-evoked neuronal activity, primarily via their robust inhibition of the dendrites of
excitatory pyramidal neurons. However, the functional roles of the diverse classes of SST-INs in deep cortical
layers remain unknown. Furthermore, whereas the role of SST-INs in superficial cortical layers of adult animals
has been well characterized, their function in the infragranular layers is unknown. Our preliminary data suggest
the properties of SST-Ins vary across different cortical layers and thus may serve different roles. To further
explore this observation, we propose to combine a number of methodological approaches, including optogenetic
manipulations, 2-photon and viral tracing. We will test the following hypotheses: (1) SST-IN populations in
superficial and deep layers of visual cortex have distinct responses and differentially regulated by behavioral
state due to differences in presynaptic inputs. (2) SST-IN populations are functionally distinct across the layers
and differ in their impact on sensory processing. Our results will provide an unprecedented level of insight into
the function of SST-INs and their relationship to visual processing in the neocortex.

Public health relevance
PROJECT NARRATIVE: GABAergic interneurons play key roles in the function and maintenance of the neocortex. This proposal will determine how interneurons that express somatostatin (SST-INs) across layers contribute to the circuits underlying spontaneous and sensory-evoked neuronal activity in mouse visual cortex. We expect our findings to provide important insights into the cellular underpinnings of visual processing and behavioral state modulation by the brain.